Graduate Training in the Pharmacological Sciences

Project Summary
Modern drug discovery and development require the training of scientists who understand the
molecular, physiological and quantitative basis of drug action and specificity, and who can apply modern
technologies and concepts to the development of novel therapeutic strategies. This multidisciplinary doctoral
training program in the Pharmacological Sciences is designed to help meet that demand by preparing students
for biomedical research careers in schools of medicine, dentistry and pharmacy, in research institutes, and in
governmental or industrial laboratories. The most important component of training is laboratory research, first
as a series of research rotations, then in the dissertation laboratory. This training is complemented by core
courses in pharmacology that emphasize quantitative analysis of drug action, pharmacokinetics, drug
disposition, biostatistics and experimental design, in addition to ethics training, seminar courses, journal clubs,
and advanced courses in specialty areas. Emphasis throughout is placed on training in rigor and
reproducibility, professional development, research ethics, and the refinement of communication skills. The 54
training faculty members represent 16 basic science and clinical departments at Emory, thereby providing a
wealth of diverse research training opportunities. This is an application for a new program, which would
replace the current program that has successfully trained a diverse cohort of students for the biomedical
workforce over the past two decades. We plan to continue our track record of training success while also
introducing new and innovative aspects to the training together with evidence-based mechanisms to evaluate
both student and program outcomes. We are requesting 8 positions, with the typical duration of appointment
being 24 months. Graduates of this program will have acquired broad familiarity with pharmacology, deep
knowledge in the area of dissertation research, and the technical, communicative and analytical skills
necessary to succeed in the biomedical workforce. The research conducted by the trainees in this program will
advance our knowledge of disease processes and contribute to the discovery of novel therapeutic strategies
that will benefit the health of our citizens. By preparing young scientists to contribute to and lead the nation’s
efforts in these areas, this training program will help to ensure that our ability to improve the nation’s health
remains strong in the future.

Public health relevance
Project Narrative This application requests funds to support the training of 8 graduate students per year in an interdisciplinary Pharmacological Sciences graduate program. Fifty-four training faculty from 16 departments provide a wealth of diverse research training opportunities for students. The goal is to produce broadly trained scientists who will contribute to the biomedical workforce, especially to the discovery, development and regulation of novel therapeutic agents that will improve healthcare in the United States and worldwide.